CMA: Pulmonary and Systemic Effects of Deployment Related Particulate Matter Exposures

Over 2.7 million military personnel were deployed to Afghanistan, Iraq, and other countries in Southwest Asia
and exposed to high levels of particulate matter ≤2.5 µm in diameter (PM2.5, particles small enough to deposit
in the small airways and alveoli) from frequent dust storms, burn-pit smoke (waste burning), and poorly
regulated industrial and vehicular sources. Previous studies have reported that deployed personnel have
experienced symptoms consistent with chronic respiratory disease. However, objective evidence of exposure-
related health effects is limited. To address this concern, VA Cooperative Study #595 “Service and Health
Among Deployed Veterans (SHADE)” is being conducted to examine the hypothesis that greater cumulative
exposure to PM2.5 while deployed is associated with lower lung function assessed by spirometry. A key
strength of SHADE is an exposure assessment approach that will use of historical satellite and regional
visibility records to reconstruct deployment-related PM2.5 in 5000 Veterans assessed at 6 centers.
A limitation of spirometry is that it is insensitive to early lung disease. This proposal is one of three
collaborative projects to systematically examine the pulmonary and systemic consequences of exposure during
deployment. We will conduct additional assessments in 280 SHADE participants (70 at each of four sites;
Boston, Minneapolis, Seattle, Houston) with and without respiratory symptoms (cough, wheeze, dyspnea) as
assessed on the CSP #595 respiratory health questionnaire and with little smoking history (former smokers
with <10 pack years or never smokers). In the Boston proposal we will use CT imaging to test the hypothesis
that Veterans deployed to Southwest Asia and Afghanistan will have evidence of structural lung disease
associated with respiratory symptoms, a lower FEV1, and deployment-related PM2.5.
In addition to structural assessment by CT scan, as part of each collaborative proposal, participants will also
have (a) assessment of systemic biomarkers and immune cell activation (lead by Minneapolis and Houston
VA), and (b) additional physiologic characterization using diffusion capacity (gas exchange), exhaled nitric
oxide (eosinophilic airway inflammation), and IgE and eosinophilia (allergy) (lead by VA Puget Sound). We will
test the hypothesis that greater exposure to deployment-related PM2.5 results in specific airway and lung
parenchymal endotypes that could be distinguished by functional, structural, and biochemical mechanisms.
Our three coordinated proposals will complement CSP #595 by comprehensively characterizing early
deployment-related lung findings related to PM2.5 exposure that may in the future be used to assess disease.
The resultant exposure-related disease types identified provide new clinical applications for the recognition,
management, and future treatment strategies for Veterans with deployment-related lung disease.

Public health relevance
Military personnel deployed to Afghanistan and Southwest Asia were exposed to high levels of fine particulate matter. Although there is concern about adverse respiratory health effects, objective evidence of exposure- related disease is limited. We will conduct respiratory health assessments in 280 participants in VA Cooperative Study #595 “Service and Health Among Deployed Veterans (SHADE)” at four sites (Boston, Minneapolis, Seattle, Houston). CT imaging will be used assess whether these Veterans have structural lung disease and will be combined with health assessments from the other sites. This information will be use to define exposure related pulmonary disease that will have clinical utility for the recognition of Veterans with deployment-related lung disease and the development of future treatment strategies.